2021 Phagocytes Gordon Research Conference and Gordon Research Seminar

Project Summary The 21st Phagocyte Gordon Conference (GRC) and associated Gordon Research Seminar (GRS) will be held June 6-11, 2021 at Waterville Valley, New Hampshire. Phagocytes are defined by their ability to ingest other cells/particles and include neutrophils, monocyte/macrophages and dendritic cells. These cells play central roles in innate and adaptive immunity. However, these cells are also critical for maintaining tissue homeostasis, and, when dysregulated, cause pathological changes that contribute to some of the prevalent diseases seen globally, including atherosclerosis and diabetes. The theme of the 2021 Phagocytes GRC is “Phagocyte-Centric Perspectives on Health and Disease: From Actin to Zebrafish” and it will be a forum for in-depth discussions of the most recent discoveries in phagocyte biology. Featured topics will include macrophage influences on cancer biology, neutrophil precursors and their generation, autophagy and cell death mechanisms, inflammasomes, phagocytosis, host-pathogen interactions, phagocytes functional and phenotypic plasticity in different tissue environments, and exciting advances in technological advances for the study of phagocytes. The role of phagocyte dysfunction on prevalent diseases and novel translational approaches will also be discussed in the meeting. The conference draws from a world-wide group of scientists with backgrounds in cell biology, molecular genetics, microbiology, immunology, bioengineering, and clinical medicine. The meeting is an important venue for disseminating information and facilitating communication between investigators studying different facets of phagocyte function and provides a networking forum for trainees and young investigators. The average attendance is 148 attendees. In 2019, 47.8% of the attendees were women and more than 50% of attendees were graduate students or postdocs. For 2021, we have recruited 13 Male and 12 Female speakers including our Keynote speaker. The program planned for the 2021 GRC includes nine sessions, chaired by discussion leaders who are experts in the field, where 25 invited speakers will present their latest and most exciting unpublished findings. In keeping with tradition, 12 junior scientists will be selected to present short talks based on their submitted abstracts and another 16 to give a brief preview of their poster. In addition to oral presentations, we expect at least 100 posters to be displayed at the meeting. To further promote the participation and professional development of students and postdoctoral fellows, the 2021 Conference will incorporate a Gordon Graduate Research Seminar (GRS) immediately prior to the start of the GRC (June 4-5) that is organized by trainees. This multifaceted program will provide opportunities for participation of scientists at all levels and promote the participation of junior investigators, postdoctoral trainees and new investigators to the field. Based on its' history, the Phagocytes GRC and GRS meetings will promote information exchange and collaborations that will drive the discovery of novel therapeutics.

Public health relevance
PROJECT NARRATIVE Phagocytes are white blood cells that are essential for human health and defense against infection but, when dysregulated, play a role in some of the most prevalent human diseases seen globally including viral infections, cancer, cardiovascular diseases and neurological diseases such as Alzheimer's disease. The Gordon Research Conference on Phagocytes, together with the preceding Gordon Research Seminar, brings together leading scientists from around the world, as well as junior Investigators that are the future of the field of phagocyte biology, in a venue that fosters discussion of the latest and most cutting edge research. The Gordon Research Conference on Phagocytes provides, in a collegial and diverse atmosphere, an ideal setting for the conception of ideas that may lead to new therapies or treatment regimens that are desperately needed to combat a wide range of infectious and inflammatory diseases and disorders.